An iPSC-derived human organoid based model of intestinal filovirus infection

Abstract
Filoviruses are prime examples of zoonotic viruses that cause fulminant hemorrhagic diseases in humans
and nonhuman primates (NHP), resulting in death in up to 90% of human case. The filoviridae family contains
six genera in which several species are known to have high fatality rates, all of which are within
the Marburgvirus or Ebolavirus genera and will therefore be the focus of this proposal. The largest ever 2014
Ebola virus (EBOV) disease outbreak in West Africa underscored the development and regulatory approval of
antiviral countermeasures, including an emergency-use vaccine and therapeutic monoclonal antibodies. While
these countermeasures are highly beneficial to block EBOV infection and interfere with disease progression at
early stages, they are less suitable for the treatment of late-stage EBOV disease (EVD), which is less studied.
Late-stage disease is characterized by gastrointestinal manifestations including diarrhea. At present, no
available animal models, including the classical NHP model, can recapitulate the gastrointestinal symptoms of
EVD patients. To elucidate the role of the intestinal epithelium in disease initiation and progression, we propose
to establish an intestinal filovirus infection model using human induced pluripotent stem cells (hiPSC)-derived
human intestinal organoids (HIOs).
We hypothesize that infection with EBOV and MARV compromises barrier integrity of the intestinal
epithelium and causes abnormal ion flux as the basis for gastrointestinal dysfunction and diarrhea. This
project proposes the establishment of a polarized 2-dimentional HIO transwell system that will be used to study
the pathophysiological effects of filovirus infection on intestinal epithelial integrity. In Aim 1, we will characterize
filovirus-mediated injury by analyzing (1) intestinal barrier and (2) tight junction integrity. We hypothesize that the
sepsis-like syndrome that occurs in some patients with severe disease may be due to loss of epithelial barrier
integrity in the intestine. In Aim 2, we intend to validate the role of individual genes by genetic ablation and test
potential drug candidates as modulators of intestinal epithelial function. We hypothesize that if tight junctions are
compromised in infected HIOs, then treatment with small molecule inhibitors targeted at ion exchanger would
reverse the leaky junctions by blocking the receptor responsible for the disassemble of the junction. The aims
proposed in this study will result in an improved model which more closely recapitulates in vivo intestinal epithelial
phenotypes, and thus can be used to inform novel therapeutics targeted at late-stage filovirus infection.
The successful, longstanding mentorship of Drs. Mostoslavsky and Mühlberger, the collaborative support of
the CReM, the availability of the NEIDL research facilities and the rigorous MTM training program will provide
me with the tools and support needed to successfully complete my dissertation work. These departments instill
important values about the rigorous approach to academic science by supporting technical training, writing
workshops and seminar and lecture series.

Public health relevance
PROJECT NARRATIVE Ebola virus (EBOV) and Marburg virus (MARV) cause fulminant disease in humans with alarmingly high fatality rates. Given the prevalence of gastrointestinal symptoms associated with Ebola virus diseases (EVD) and Marburg virus disease (MVD) presentation, the study of EBOV and MARV infection in intestinal cells is of clear clinical relevance and importance. The goal of this proposal is to study the mechanisms by which EBOV and MARV infections cause gastrointestinal manifestations, particularly intestinal diarrhea, using novel infection platforms based on induced pluripotent stem cells (iPSC)-derived human intestinal organoids and their ability to recapitulate intestinal filovirus infection.